Core G: Clinical Cohort and Comorbidity Research

ABSTRACT
The widespread use of antiretroviral therapy (ART) has markedly changed the course of HIV disease and
increased life-expectancy. However, evidence suggests that higher incidence of age-related comorbidities than
would otherwise be expected, including cardiovascular disease and cancer, are contributing to a growing
burden of multimorbidity among HIV-infected individuals and early death even with virally-suppressive ART.
Resources developed by the Clinical Cohort and Comorbidity Research Core over the past 20 years position
us uniquely to support multidisciplinary research designed to improve our understanding of the evolving
treatment, progression, comorbidities, and outcomes of HIV infection in the contemporary ART era. We enter
this next 5-year cycle with a well-established clinical cohort, research platform, study recruitment and specimen
collection service that will be enhanced to serve a growing number of local, national and international
investigators and an expanding HIV clinical, epidemiological, behavioral, basic and translational scientific
agenda. We are proposing aims that capitalize on our uniqueness, our comprehensive accumulation of patient
data with broad clinical scope and extensive longitudinal follow-up linked to biologic specimens, and ready
access to study participants that enable projects to move rapidly from concept proposal to publication. Aim 1:
We will expand the UW HIV Information System, UW HIV Clinical Cohort, and novel web-based platforms
to capture and validate new data necessary to frame, design, and successfully answer central questions in
contemporary HIV medicine and address emerging research priorities over the next five years. Aim 2: We will
facilitate high-impact clinical research that will advance prevention and treatment of HIV-associated
cardiovascular, metabolic, neurologic, pulmonary, liver disease and cancer to improve outcomes among
persons aging with HIV. We will promote HIV Comorbidity Research Collaborations with local experts and
leadership by early-career investigators to identify future scientific directions and target outcome adjudication
required to define the clinical course and consequences of HIV-associated comorbidity and the impact of
multimorbidity on survival. Aim 3: We will support cutting-edge basic and translational HIV research
investigating biologic mechanisms of comorbid disease, HIV pathogenesis, progression, and approaches to
HIV cure by recruiting study participants, providing banked specimens, and procuring protocol-driven and
expanded types of specimens that investigators need for their research. Services provided by the Core will
strengthen and expand collaboration among local investigators, foster synergy with other Cores and Scientific
Working Groups, link early-stage investigators with established HIV scientists across disciplines, and create
ties with scientists at other CFARs and HIV research centers, including through our leadership of the CFAR
Network of Integrated Clinical Systems, necessary to combat the global HIV epidemic.
3